NorthStar Node of the Clinical Trials Network-Madison Partnership

Project Goals: • Explore the feasibility of a system for providing MOUD distribution for categories of MOUDs (e.g., injectable, oral ingested at home, oral ingested under observation) via pharmacies; Identify the viability of this system for each category of MOUD. • Identify system barriers and/or gaps for any MOUDs that pharmacies cannot deliver at this time, and the changes needed before pharmacies could deliver those MOUDs. • Create a model system design for pharmacy distribution and continuity of care for those categories of MOUDs determined to be viable.

Public health relevance
The purpose of this project is to conduct a small pilot study intended to design a sustainable system to widely and cost-effectively disseminate medications for opioid use disorder (MOUD) in rural, suburban, and urban areas across the USA via collaboration between clinicians and pharmacies.